Mechanisms of Disease

PROJECT SUMMARY/ABSTRACT
The Mechanisms of Disease and Translational Science (MoD) Track at the University of Texas Southwestern
Medical Center (UTSW) will provide PhD students with core competencies needed to successfully engage in
translational research and prepare them for rewarding careers in biomedical research. We will annually appoint
6 first year PhD students for 12 months each. We target this junior population to “imprint” them with the
translational science mindset, and to provide iterative long term active training to enable them to seek
interdisciplinary collaborations. Rationale. Accelerating the translation of basic biomedical science discoveries
to tangible improvements in human health is a national priority. This need is now particularly urgent with the
current explosion of scientific and technological discoveries. Mission: MoD will train a new breed of PhD
translational scientists capable of targeting their research programs to address unmet therapeutic and
diagnostic needs of the future. Our students will be prepared to transition into the biomedical research
workforce in multiple professional capacities and to spearhead the bidirectional and interdisciplinary translation
of discoveries from the “bench to bedside and back” to improve human health. Objective: Create an innovative
and rigorous curriculum to foster critical thinking, rigorous and ethical research design, interdisciplinary team
science, and diversity and inclusion. Students will be equipped with both the “intellectual” and “practical” skills
to succeed during training and in their future careers. Program Design: MoD is a “supplemental” track
overlaid on the 11 existing PhD graduate programs. Our innovative and rigorous curriculum, intense multi-
tiered mentoring and career development programs will allow students to achieve a full menu of competencies
required to conduct rigorous translational research and to succeed. Students will be immersed in unique
opportunities to study human diseases at the interface between basic and clinical sciences. They will be
exposed to clinical translational science through small group learning, structured experiences in patient care,
and immersion in clinical research. MoD will foster student career development, by offering experiential training
in team science, grant writing, leadership, entrepreneurship and communications. Students are required to
design and execute the “bench to bedside & back” mini-internship with clinicians in their third year, and are
encouraged to seek additional internships to “test-drive” potential future careers. Additionally, our translational
science work-in-progress format will bring together a diverse cross-section of clinical and translational trainees
and researchers operating across the T0-T4 translational science spectrum. These interactions will promote
exchange of ideas and accelerate bidirectional translation. Anticipated outcomes include increasing student
engagement in translational research, as measured by grants, publications, time to degree, interdisciplinary
collaborations, and career placement. Our MoD plan is innovative, sustainable, and cost-effective. MoD has an
eleven-year history of success, and will leverage multiple institutional resources to ensure future success.

Public health relevance
Project Narrative The Mechanisms of Disease and Translational Science Track at University of Texas Southwestern Medical Center will train PhD students in translational research to enable them to address unmet therapeutic and diagnostic needs of the future. This training will promote translation of basic and preclinical research to improve human health.